A soft magnetoelastic microneedle patch for rapid skin cancer screening

PROJECT SUMMARY
Over 2.5 million skin cancers are diagnosed annually in the United States, more than all other forms of cancers
combined. Early diagnosis is critical; thus, we propose to develop a soft and wearable magnetoelastic
microneedle patch (MMP) for non-invasive and rapid skin cancer screening. It could perform fast scanning of the
spatial stiffness of skin lesions with depths of up to 5 mm. This concept is established on the basis of the PI’s
prior success in discovering the giant magnetoelastic effect in soft matter (Nat. Mater. 2021, 20, 1670). With a
fundamentally new working mechanism, the proposed soft MMP can cover a large detection area (7.7 cm2) and
have a high spatial resolution (1 mm, trained with super-resolution algorithm), high framerate (2000 Hz), and
ultrahigh sensitivity (<2 kPa). We hypothesize that the proposed soft MMP enables fast, non-invasive scanning
of skin stiffness of both lesions and borders spatially, which can be used experimentally and/or in clinics for skin
cancer early diagnosis and screening, longitudinal monitoring, and/or guiding cancer excisions. To test our
hypothesis, we propose three aims. Aim 1: Scalable design and optimization of a soft MMP for fast spatial
stiffness mapping. Aim 2: Validate the soft MMP via stiffness mapping in mice models with skin cancer. Aim 3:
Validate the soft MMP via stiffness mapping in excised human skin cancer.

Public health relevance
PROJECT NARRATIVE This proposal aims to develop a soft magnetoelastic microneedle patch that enables the study of in vivo, rapid, and non-invasive characterization of skin mechanical properties on human subjects and establish its clinical significance for the pre-screening and early diagnosis of skin cancer. Moreover, the wireless transmitting features can provide extra information on time-dependent changes of tissue, facilitating further understanding of skin cancer progression. Such platform technology includes not just monitoring the stiffness of the tumor, but also stiffness changes during aging, wound healing, or other treatment processes.